A bioluminescent-based imaging probe for noninvasive longitudinal monitoring of CoQ10 uptake in vivo

PROJECT SUMMARY
Coenzyme Q10 (CoQ10) is a potent energy transfer molecule and a central cofactor in oxidative phosphorylation
present in both cell membranes and mitochondria. CoQ10 is also known as a powerful anti-inflammatory and
antioxidant agent that protects the tissues from the damage resulting from the activation of inflammatory
signaling pathways and free radicals. It is naturally synthesized at high levels in the liver, heart, and kidneys.
However, the ability of the body to synthesize its own CoQ10 significantly decreases with age. In addition to the
regular aging process, significant decrease in CoQ10 levels have been identified in a number of human
pathologies. Therefore, nutritional supplementation with CoQ10 provides a powerful tool to maintain its sufficient
levels in the body with the goal to improve human health and reduce the risk of chronic diseases. In this context,
multiple clinical trials revealed potential benefits of CoQ10 supplementation in cardiovascular diseases, neuronal
and muscular degenerative diseases, statin-induced myopathy, high blood pressure, migraine, cancer, and many
others. However, the variable success in the outcomes of many of such clinical trials is thought to be due to the
lack of knowledge of the biological process determining cellular uptake, gastrointestinal absorption, and
subsequent bioavailability of CoQ10. These unresolved issues significantly slow down clinical translation and
further expansion of CoQ10 therapeutic applications. Thus, it is of critical importance to understand the
biological processes that regulate CoQ10 uptake and to optimize its oral bioavailability, which remains
to be one of the main challenges in CoQ10 supplementation. However, the progress of studying exogenous
CoQ10 fluxes is significantly hampered by the lack of tools and no imaging techniques currently exist for
noninvasive longitudinal monitoring of CoQ10 uptake. To address the unmet need for nutrient uptake imaging
tools, we are currently developing a novel analytical platform based on a combination of versatile “click” chemistry
reactions with noninvasive and ultrasensitive bioluminescent imaging (Optical platform for functional longitudinal
imaging of metabolite uptake in vivo, 1-R01-EB034607-01A1). The method is independent of radioactive and/or
short-lived isotopes, less costly, and allows longitudinal monitoring of metabolite absorption. While the first
application of this approach was successfully validated by us using glucose and nicotinamide riboside, a form of
vitamin B3, as an example (Nat Methods, 2019 and Biosens. Bioelectron. 2023), we are now expanding this
technology to study uptake of different amino acids, fatty acids, and nucleosides, which all play a central role in
many human pathologies. Since the design of the probes is based on noninvasive imaging, more data could be
collected from a single animal enabling better reproducibility. Here, we propose to apply this versatile method
to develop a novel imaging tool for noninvasive, longitudinal measurements of CoQ10 uptake both in
vitro and in vivo. This novel probe will provide a unique opportunity for understanding CoQ10 uptake, tissue
distribution, and will become a valuable tool for optimizing its oral bioavailability.

Public health relevance
PROJECT NARRATIVE Coenzyme Q10 (CoQ10), a powerful antioxidant naturally produced by the body, is essential for many cellular functions and its deficiency has been implicated in a wide range of human diseases. However, the variable success in the outcomes of many of clinical trials investigating beneficial properties of CoQ10 supplementation is thought to be associated with significant gaps in knowledge of CoQ10 biological mechanism of uptake, tissue distribution, and bioavailability. Thus, it is of critical importance to develop novel noninvasive tools that would enable our understanding of the biological processes that regulate CoQ10 uptake and facilitate optimization of its oral bioavailability, which remains to be one of the main challenges in CoQ10 supplementation.